NEUROSCIENCE OF HIV

DESCRIPTION (Adapted from the Applicant's Abstract): This application seeks support for the conference, "The Eighth International Neuroscience of HIV Infection: Basic and Clinical Frontiers 1998" to be held in Chicago, Illinois, June 3rd-6th, 1998. The goal of this conference, formerly a satellite symposium to the International Conference on AIDS, is to bring together the world's experts in the pathophysiological mechanisms and clinical manifestations of the neurological, neuropsychological, and psychiatric complications of human immunodeficiency virus (HIV) infection. The conference serves as a means to disseminate new information on the pathogeneses and manifestations of the broad range HIV-related disorders of the nervous system. This international conference on the neuroscience of HIV was conceived and developed in 1988 when the co-founders (Drs.J. Berger and R. Levy) recognized the limited forum available to neuroscientists at the International Conference on AIDS, for the presentation and discussion of works related to the effects of HIV on the nervous system. The first annual meeting held in Quebec City, prior to the 5th International Conference on AIDS in Montreal, had over 220 participants from around the world. Subsequent sites of the conference have included Monterey, California (1990), Padua (1991), Amsterdam (1992), Vienna (1993), Vancouver (1994), and Paris (1996). Attendance at the conference has varied from 150 to 275 persons, with worldwide representation. The conference has served as a mechanism to encourage young investigators in the discipline. The format for the conference is a combination of plenary sessions by internationally recognized authorities in association with scientific (both platform and poster) presentations. With the maturation of the conference, by laws and an advisory board of international experts, broadly representative of the neuroscience of HIV, have been established for the conference.